Enhancing immune mediated head and neck cancer anti-tumor activity using nanoparticles

ABSTRACT
For patients with head and neck cancer whose tumors are HPV negative, current therapy does not lead to sig-
nificant longevity and most succumb to loco-regional recurrence of the primary tumor. We discovered that
HPV(-) head and neck cancer patients fit into four distinct categories relative to their PD-L1 and CD8 status.
These categories had discrete outcomes such as loco-regional recurrence and disease-specific survival, with
CD8 and PDL-1 double positive patients faring worse than any other patient cohort. We asked if we can de-
velop treatment strategies that can leverage the unique biology of these patient categories. We posit that pres-
ence of PDL-1 either blocks infiltration of CD8+ cytotoxic T cells or leads to exhaustion of T cells that do make
it to the tumor parenchyma. Postulating further, we asked if overexpression of surface PDL-1 can be used as a
homing mechanism for radiosensitizing gold nanoparticles. We also asked if blocking PDL-1 could replicate the
tumor response of PDL-1 negative cohorts. Finally, we considered strategies that can increase immunogenicity
of tumors that lack PDL-1. In this proposal, we ask three main questions: 1) Can we use PDL-1 to home gold
nanoparticles and enhance radiation specifically within tumor cells? We hypothesized that overexpression of
PDL-1 may serve as the ideal homing strategy for radiosensitization. Gold nanoparticles are well described
radiosensitizers that are easily targeted to tumors via antibodies. We will conjugate spheroid gold nanoparticles
to α-PDL-1 and examine their efficacy in vivo for tumor control and overall survival. 2) By what mechanism is
PDL-1 blocking the activity of infiltrating cytotoxic T cells and can this mechanism be overturned? Using a
syngeneic model of head and neck cancer, we will investigate if eliminating PDL-1 by genetic manipulation or
an inhibitory antibody can improve tumor control following genotoxic therapy. We will further profile the T cell
infiltrate from both the human tissues and the animal tumors and ask if the profile changes following PDL-1 in-
hibition. The goal is to understand if PDL-1 overexpression in tumor cells is simply correlative to or causative of
the systemic immune inhibition. 3) Can radiation increase immunogenicity of dying tumor cells? We present
data to demonstrate that radiation with high linear transfer energy (LET), which can be achieved by particle
therapy, increased immunogenic signals from tumor cells in vitro. Therefore, we will investigate if treatment
with proton beams with high-LET can achieve a similar effect in vivo. Finally, as a test of a three-hit strategy,
we will examine the tumor control that can be achieved by combining α-PDL-1 tagged gold nanoparticles with
high-LET proton radiation. We anticipate that this treatment will block T-cell exhaustion, enhance radiation ef-
fects, and increase the immunogenicity of dying tumor cells. Our understanding of the interplay between tumor
biology and the immune system suggests that new strategies will have to be developed that can merge our
knowledge of nanotechnology, radiation response, and immunology into sophisticated and innovative treat-
ment strategies.

Public health relevance
PROJECT NARRATIVE We discovered that patients with HPV(-) head and neck cancer can be categorized based on their PD-L1 and CD8 status into 4 cohorts with distinct disease-specific outcomes. In this grant, we asked if we can design novel treatments combining nanotechnology, immunology, and radiation oncology that can lead to curative out- comes. The strategies will be evaluated for efficacy in isolation and in combination using in vivo models of head and neck cancer.